Investigating the Novel Disease Pathways Associated with C9orf72-Linked ALS/FTD

Project Summary
Neurodegeneration is an increasing public health issue and remains an unsolved biomedical
challenge. Genetic discoveries have provided new avenues for investigating the molecular
mechanisms of several neurodegenerative diseases. A hexanucleotide repeat expansion in a
noncoding region of the C9orf72 gene was linked to the neurodegenerative disease
amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD). ALS is characterized by
loss of motor neurons, and the C9orf72 mutation represents the most common genetic cause of
both familial and sporadic ALS. FTD is characterized by degeneration of the frontal and
temporal lobes of the brain and is the second most common type of dementia for people
younger than 65; the C9orf72 mutation is also the most common genetic causes for FTD. The
C9orf72 mutation is also found to contribute to Alzheimer’s disease and Huntington’s disease.
Despite intense efforts and rapid advances, our understanding of the disease mechanisms and
treatment strategies for C9orf72-linked ALS/FTD are still at the early stages. To help relieve the
public health burden associated with these diseases, it is important to understand the
mechanisms underlying the pathogenesis. We have recently discovered that C9orf72 is
localized to specific cellular compartments, suggesting that further studies of basic C9orf72
functions as well as gained toxicity arising from the expanded repeat could shed light on the
mechanism of ALS/FTD pathogenesis. The long-term goal of the proposed project is to
elucidate the mechanisms through which dysregulation of C9orf72 functions and the repeat
expansion leads to molecular defects and neuronal toxicity. The aims are to identify and
characterize a novel function of C9orf72, to delineate the pathways C9orf72 expression is
regulated, and to uncover the mechanisms of the other pathologies associated with the C9orf72
repeat. The proposed studies, which combine biochemical, molecular, and genetic approaches,
are expected to provide insight into fundamental mechanisms of neurodegeneration in ALS/FTD
that may ultimately leads to novel approaches for treating these devastating neurodegenerative
diseases.

Public health relevance
Project Narrative The work in this proposal is aimed at elucidating the basic molecular mechanisms of pathogenesis underlying neurodegenerative diseases that are associated with a genetic anomaly in C9orf72, including amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD). As these diseases pose a growing public health concern in the aging society, the underlying mechanisms of many neurodegenerative conditions are still not well understood. The biochemical, molecular, and genetic studies proposed here have the potential to build the foundation for innovative therapeutic strategies for these diseases.